Supplement: Effects of Comorbidity Management and Complex Care Coordination on Cancer Caregivers

PROJECT SUMMARY. The overarching goal of this Diversity Supplement is to prepare and launch Dr. Maria
Lizette Rangel into an academic career as an independent scientist. Dr. Rangel is a behavioral scientist and
post-doctoral research associate with a strong commitment to working with medically underserved cancer
patients, families, and communities. Through this Diversity Supplement, she will gain crucial training in cancer
control research focusing on cancer caregiving, challenges of comorbidity management during/after cancer-
directed treatment, and advanced statistical analysis. With an eye toward developing interventions to support
caregivers in managing patient comorbidities across the cancer control continuum, specific aims of this
supplemental research are to: 1) Examine whether patient participation in the parent OPTIMISE (Oncology-
Primary Care Partnership to Improve Comprehensive Survivorship Care) enhanced care pathway for comorbidity
management results in improved outcomes for caregivers in terms of lower levels of caregiver burden, distress,
and financial hardship relative to usual medical care (UMC); 2) Describe the challenges that caregivers face in
managing patient comorbidities during cancer-directed treatment; and, 3) Describe the challenges that
caregivers experience as the patient transitions from cancer-directed treatment to post-treatment survivorship.
Dr. Rangel will achieve these aims by recruiting the caregivers of patients who are eligible and enrolled in the
parent OPTIMISE trial and conducting a mixed-methods companion study using caregiver interview and survey
data. To supplement the research plan, career development goals include 1) gaining a foundational
understanding of cancer control health equity research, 2) develop theoretical and conceptual knowledge in
cancer caregiving research, 3) continue developing the methodological and analytical qualitative, quantitative,
and mixed methods skills required to conduct rigorous mixed methods research, and 4) acquire professional
development skills to support a career as an independent investigator. Along with the valuable training and
career development opportunities afforded through this supplement, the findings supported by Dr. Rangel’s
research will provide crucial data on the unmet needs of cancer caregivers and enable her to develop a
competitive K99/R00 proposal to develop an intervention for caregivers of cancer patients with comorbidities and
launch her career as an independent investigator.

Public health relevance
PROJECT NARRATIVE Medically underserved patients have the highest burden of multiple chronic conditions and are at increased risk for poor cancer outcomes. Despite the increased need for caregiving and care coordination, little is known about how patient comorbidities and comorbidity management affects caregivers. This supplemental research will elucidate caregiver experiences during and after cancer-directed treatment and in so doing, yield crucial preliminary data to launch Dr. Rangel’s career as an independent investigator.